Immunoreceptors and Immunotherapy

Abstract
The goal of this application is to secure funding for the 2024 FASEB summer research conference (SRC) on
“Immunoreceptors and Immunotherapy”. This successful SRC has been running since 1987 and has fostered a
highly interactive community of international researchers with the goal of solving important problems in
immunoreceptor and immunotherapy biology. Immunoreceptors play a central role in cancer, autoimmunity and
infectious diseases, whilst immunotherapy is the rapidly expanding field focused on stimulating the immune
system to fight cancer and other inflammatory diseases to change people’s lives in the clinic. The meeting
program is composed of the best science related to immune receptor function, immune cell signaling, and the
physiology and pathology of immune diseases. We also highlight emerging topics including inhibitory receptors
and antibody engineering, along with immunotherapy in cancer and autoimmunity, and the new topic
organization of immunoreceptors on the membrane. Our speakers represent leaders in the field as well as early-
and mid-career investigators. The speakers have been selected to feature cutting-edge aspects of
immunoreceptor and immunotherapy biology, covering the range from basic science to translational applications.
The program also includes state-of-the-art technologies in imaging, structural analysis, computational modeling,
systems biology and therapeutic approaches. As such, this meeting brings together scientists from different
fields, creating a dynamic and interdisciplinary environment for building networks and developing new
collaborations. The FASEB SRC provides an ideal format for this meeting, because interactions between
participants is guaranteed by the size of the meeting, multiple poster sessions and shared meals. This R13 will
be exclusively used to financially support trainees and young investigators to attend and present at the
conference. This meeting is committed to sustain diversity, equity, accessibility, and inclusion (DEAI) in science
through a diverse selection of speakers, use of travel awards to enable underrepresented researchers’
attendance and introduction of a new DEAI roundtable discussion. Other networking opportunities, including a
“meet the expert” luncheon and Career Workshop will further help to foster connections between young
investigators and senior researchers. With this SRC program, we aim to encourage intensive scientific discussion
that promotes new collaborations among the international community engaged in immunobiology research.

Public health relevance
Narrative This application requests NIH support for a conference that brings together an interdisciplinary and diverse group of scientists who are focused on solving important problems in immunobiology. This meeting will highlight the latest technological advances in immune cell research, with a focus on understanding immune receptor function and the complexities of immunotherapy. This research is very important to human health because it helps to drive new therapeutic strategies for harnessing the power of immune cells in targeting diseases, including autoimmunity, infectious disease and cancer.